From cell-to-cell heterogeneity to collective behaviors in bacterial biofilms

PROJECT SUMMARY
Bacterial biofilms are communities of bacteria stuck together by a self-produced polymer matrix.
They exist in nearly every environment on earth and are the cause of most hospital-borne
infections. These adherent communities are highly tolerant of antibiotics and their extreme
resilience cannot merely be attributed to the inability of drug molecules to penetrate the biofilm
matrix. It has become clear that emergent, multicellular behaviors in biofilms impart unique
survival strategies. In recent years, we have learned detailed mechanisms of gene regulation
and phenotypic heterogeneity of single bacterial cells, but we have neither explored these
cellular phenomena in the context of crowded, multicellular biofilms, nor do we understand how
multicellular behaviors emerge from these single-cell properties. The goal of my lab for the next
five years will be to understand how single-cell properties and physics of the local environment
give rise to beneficial emergent behaviors in biofilms. With this MIRA award, my group will
explore these questions by focusing on two collective phenomena: 1) electrical cell-to-cell
communication and 2) emergence of patterns of motile and matrix-producing cells during biofilm
development. We will approach these problems using spatial gene expression measurements,
single-cell-level time-lapse imaging of biofilms, and novel transistor devices for electrical
perturbation of biofilms. To probe the emergence of group behaviors from single-cell properties,
we will use the experimental biofilm model species Bacillus subtilis to perturb known cell-to-cell
communication mechanisms and gene regulatory circuits. Our data will inform quantitative
models of multicellular phenomena, which will give us a system-level understanding of
multicellular behaviors in microbes, as well as suggesting new hypotheses and targets for
disrupting the emergent behaviors that allow biofilms to elude treatment.

Public health relevance
PROJECT NARRATIVE Bacterial biofilms exhibit multicellular behaviors that allow them to tolerate antibiotics and thrive in low nutrient environments. The goal of this proposal is to uncover how these collective behaviors emerge from single-cell-level properties and cell-to-cell interactions. This work is relevant to the NIH mission because it will lay foundations for new ways to target emergent behaviors that make biofilms extremely resilient.